Core 2: Computational and Data Integration

COMPUTATIONAL AND DATA INTEGRATION CORE SUMMARY
The primary objective of Core C is to strengthen the New York University Langone Health (NYULH) Metastasis
Research Network Center’s research goals by providing standardized, robust, and harmonized workflows to
acquire, analyze, integrate, visualize and share data from single cell RNA sequencing, spatial transcriptomics,
digital spatial profiling and highly multiplexed microscopy platforms that are utilized by all three research projects
and Core B.
Core C will build on multi-dimensional molecular and tissue histology data that are generated with specimens
obtained from both genetically engineered melanoma mouse models and patient specimens to: 1) develop and
use a computational analysis pipeline that is robust, transparent, reproducible and scalable; 2) integrate
metastasis driving molecular features of melanoma cells, stromal fibroblasts and lymph-nodes in space and time
with data from complementary technology platforms; and 3) build a web based dashboard that will allow basic
scientists and clinicians to analyze, explore and visualize this complex molecular and spatial information in an
intuitive and meaningful way.
We envision that our robust data analysis pipelines and interactive data visualization platforms will foster inter-
disciplinary collaborations within the larger metastasis field and spark new ideas to strengthen our understanding
of early tumor cell dissemination, cross talk between tumor cells and their cellular and molecular
microenvironments and determinants of melanoma metastasis and metastatic cancer progression in general.